Transcriptomics of Stroke Thrombus to Determine Stroke Etiology and Response to Revascularization Therapies

PROJECT SUMMARY/ABSTRACT
This is a K23 award application for Dr. James Giles, a neurologist and young investigator pursuing patient-
oriented clinical research on ischemic stroke caused by large vessel occlusion. A K23 award will provide him
with the means to acquire critical skills in four key development areas: 1) computational biology for
transcriptomic analysis of tissue and blood samples, 2) the biology of thrombosis in patients with acute
ischemic stroke, 3) clinical translational project management and 4) research management and leadership. By
acquiring these skills, Dr. Giles will develop as an independent investigator who can bridge the disciplines of
computational biology and clinical research in vascular neurology. To pursue this goal, Dr Giles has assembled
a mentoring team with expertise in translational transcriptomic analysis. Complementing them is an advisory
team with expertise in computational biology and statistics, atherothrombosis and immunobiology.
Acute ischemic stroke caused by thrombi occluding large cerebral vessels is associated with significant
mortality and morbidity. Despite emergency revascularization, via intravenous thrombolysis and mechanical
thrombectomy, poor neurologic outcomes remain common. Etiologies of thrombi include atherothrombosis and
cardioembolism. A key challenge in stroke medicine is to identify the etiology of stroke thrombi, in order to
more effectively prevent future strokes.
Dr. Giles’s central hypothesis is that the cellular pathogenesis of stroke thrombi varies between clots of
different etiologies, and that these differences can be identified via transcriptomic analysis of cells within acute
thrombi and blood samples. We will test this hypothesis with transcriptomic analysis of cells comprising acute
stroke thrombi and paired circulating blood cells. We will determine whether clots of different etiologies contain
cells of different activation statuses and transcriptional programs (Aim 1). Further, we will test the hypothesis
that blood cell gene activation within thrombi causing atheroembolic stroke are related to the clinical response
to revascularization treatments in an assembled multi-center cohort of patients with stroke (Aim 2).
The proposed research is significant because stroke due to large vessel occlusion causes substantial
mortality and morbidity and requires new precision medicine approaches to improve the efficacy of
revascularization therapies. Further, recurrent stroke continues to exert a significant burden, and new
approaches are needed to diagnose stroke etiology. The proposed research is innovative because it combines
advanced transcriptomic techniques to provide insight into mechanisms of different thrombus etiologies.
Consistent with NINDS priorities to accelerate basic research findings towards patient use, this proposal will
prepare Dr. Giles as an independent investigator who can develop new approaches for personalized, timely,
and effective revascularization and preventive therapeutics to improve outcomes among patients with stroke.

Public health relevance
PROJECT NARRATIVE Ischemic stroke caused by blood clots blocking large brain arteries remains a leading cause of death and disability. The proposed work seeks to use advanced gene expression analysis of clots retrieved during emergency thrombectomy and blood samples to identify the source of the clot in the body and why some clots remain resistant to emergency treatment. Identifying the source of the clot and how best to treat individual thrombi may optimize emergency and preventive care through precision diagnostics and treatments.